AI-driven in vivo profiling in zebrafish: a platform for alcohol use disorder therapeutic discovery

PROJECT SUMMARY
Alcohol Use Disorder (AUD) is a pervasive condition with a substantial global burden, including considerable
morbidity, mortality, and societal impact, as well as mounting healthcare costs, lost productivity, and familial
breakdowns. However, despite the high prevalence and substantial burden of AUD, there remains a significant
unmet need in its treatment. The current therapeutic landscape for AUD includes behavioral therapies, such as
cognitive-behavioral therapy (CBT) and motivational enhancement therapy (MET), which have limited
effectiveness, and a small number of therapeutic options. A major contributor to the lack of novel pharmaceutical
treatments for AUD has been that, unlike other disorders of similar prevalence, there is an absence of scalable
models capable of performing initial hit identification. Here, we will leverage:
1. Our AI-based zebrafish behavioral screening platform which has been commercially deployed for other
disease areas,
2. Our experimental findings specific to AUD in zebrafish, and,
3. Our consortium’s extensive experience in therapeutic discovery and development,
to produce a commercial platform for AUD therapeutic development, and a proprietary novel chemical series
that can be further developed as an AUD therapeutic.
Broader Impacts
Market impacts & human health: The proposed AI platform promises a more rapid and accurate identification of
potential AUD therapeutics—reducing time, resources, and financial risks associated with the traditional drug
discovery process, and ultimately tailored specifically to AUD, an area with substantial unmet therapeutic need.
We also anticipate the identification of at least one novel chemical series using this platform, which itself
represents a separate source of protectable IP and ultimately value that can be realized upon out-licensing or
further development by our consortium.
Potential for new knowledge: By leveraging AI/ML and in vivo screening in a living vertebrate, we are building a
novel platform for therapeutic discovery that specifically quantifies behavioral, morphological, and cellular effects
relevant to the three phases of AUD: binge/intoxication, withdrawal, and chronic use.

Public health relevance
PROJECT NARRATIVE Alcohol Use Disorder (AUD) is estimated to affect over 19 million Americans, many of whom do not have their symptoms related to alcohol binge/intoxication, withdrawal, or chronic use managed by the limited therapeutic options. The proposed project will develop and deploy a small molecule screening platform that leverages AI and ML to quantify in vivo phenotypes relevant to AUD at scale, enabling expedited discover of AUD therapeutics. The result will be commercial application of this platform in a partnership-based model, and development of the resulting chemical hits.